Comprehensive Phenotyping of Specific Populations of Spinal Neurons Processing Cutaneous Information Before and After Injury

ABSTRACT
Chronic pain is a debilitating condition for which there is a pressing need for safe, effective treatments. These
patients experience enhanced pain sensations and often experience pain when innocuous stimuli are
presented. However, the neural basis for this increased sensitivity is poorly understood. Here, we propose to
investigate the neural circuit basis for central hyperexcitability that may contribute to persistent pain. We will be
combining novel physiological, and pharmacological approaches to address our goals. Using existing
transgenic mouse lines, we can express the calcium indicator GCamp6s in all excitatory spinal neurons. We
can then use our novel ex vivo skin-spinal cord preparation and 2-photon calcium imaging to examine activity
in the spinal dorsal horn activity to cutaneous stimulation in naïve mice and those following injury. While this
approach will allow us to image the responses of many (~200) neurons simultaneously, it does not allow us to
identify different types of neurons, thereby severely hampering the degree to which the data can be
interpreted. Now, we have developed a novel approach to circumvent this limitation through post hoc
pharmacological identification of cell types. The underlying concept is that most neurons express one or more
Gq-coupled G-protein coupled receptors (GPCRs) whose activation results in the release of Ca2+ from internal
stores. In the presence of tetrodotoxin (TTX) to silence neuronal activity, the only neurons that show a Ca2+
transient in response to a given agonist are those that express its receptor. This approach, which we have
termed CICADA (Cell-type Identification by Ca2+-coupled Activity through Drug Activation), allows us to
unambiguously define cell types based on their responses to a series of GPCR agonists. Now we are uniquely
poised to address specific questions about the function of spinal circuitry and how the functional properties of
these circuits are altered following injury. In the first Aim we will extend and validate this analysis with the goal
of developing a complete repertoire dorsal horn subtypes that can be identified in population imaging studies.
While neurons respond to different types of sensory stimuli (e.g., heat, cold, and mechanical), how this coding
is manifest across neuronal populations is unclear. In the second Aim we will catalog functional response
properties across populations of CICADA-defined cell subtypes. In the third Aim we will examine the effects of
capsaicin induced acute central sensitization on these subpopulations. The chronification of pain is thought to
be associated with long-term changes in central network activity that perpetuate hyperalgesic states. In the
fourth Aim we will identify the CICADA-defined cell types that show altered activity in the context of chronic
pain using the spared nerve injury (SNI) as a model. The studies we are proposing here will begin to identify
specific spinal circuitry involved in central sensitization and investigate how these specific microcircuits are
altered in conditions of acute and chronic injury. This knowledge may elucidate new therapeutic targets for the
treatment of pain, which is the long-term goal of research of our program.

Public health relevance
Project Narrative Chronic pain is a serious health concern effecting millions of American annually. In this application we are proposing to use innovative physiological, pharmacological and calcium imaging approaches, together with a novel somatosensory preparation to characterize the spinal circuitry involved in processing both nociceptive and non-nociceptive information. These studies will provide new knowledge about how specific populations of spinal neurons interact to form networks that process peripheral sensory information under normal conditions and following neuropathic injury.